Clinical Trials Office

The OSUCCC Clinical Trials Office (CTO), rated

Public health relevance
RELEVANCE (See instructions): The Clinical Trials Office shared resource provides centralized administration of all clinical trials conducted within the OSUCCC. This shared resource promotes the conduct of cancer clinical trials in a methodologically sound, compliant, expedient and cost-effective manner.